Development of a latex-agglutination assay for the rapid detection of Naegleria fowleri

PROJECT SUMMARY/ABSTRACT
Development of a latex-agglutination assay for the rapid detection of Naegleria fowleri
As most diagnoses of primary amebic meningoencephalitis are done at the time of autopsy, rapid methods of
detection of Naegleria fowleri are urgently needed. In this proposal, we plan to demonstrate proof of concept that
the development of a point-of-care assay for the detection of N. fowleri in cerebrospinal fluid (CSF) is feasible.
To achieve this goal, we will inoculate rabbits with N. fowleri lysate to produce antisera. Total IgG antibodies will
be purified from animal sera and isolated to identify fractions that bind to N. fowleri. These antibodies will be
immobilized onto dyed latex microspheres to create an agglutination assay that can detect N. fowleri in CSF in
under 15 minutes without the need for additional equipment. We will compare our proposed assay to the current
methods of diagnosis, nucleic acid amplification and microscopy, in terms of limit of detection, sensitivity, and
specificity using prepared samples and CSF specimens obtained from animals infected with N. fowleri. Cross
reactivity of our proposed assay will be assessed by testing against N. fowleri and common bacterial and fungal
meningoencephalitis pathogens. Demonstrating proof of concept will allow us to seek future support to refine
our methodology to characterize the antibodies and target specific antigens so we can produce monoclonal
antibodies that will facilitate large-scale production and kit development. It is the long-term goal of this proposal
to incorporate this assay in the clinical setting as part of the screening panel for meningoencephalitis pathogens.

Public health relevance
NARRATIVE/RELATIONSHIP TO PUBLIC HEALTH Primary amoebic meningoencephalitis is a rare disease with an increased number of cases in the last five years and is currently being considered as an emerging infectious disease. As this disease is almost always fatal, proper treatment relies on quick diagnosis. This proposal seeks to demonstrate proof-of-concept that animal sera can be used as the basis for a rapid immunoassay that can detect Naegleria fowleri in cerebrospinal fluid.